Cross-talk between social determinants of health and MTOR pathway, the missing link in fatigue

PROJECT SUMMARY
Debilitating post-treatment fatigue following stereotactic body radiotherapy (SBRT) to treat prostate cancer is a
significant public health concern due to its negative impact on health-related quality of life, higher comorbidities,
and shorter survival. To date, there are limited effective targeted fatigue therapies. Limited therapeutic options
are due in part to inconsistent evidence on the individual and combined influence of social determinants of health
(SDOH) risk factors such as dietary adversity (i.e., food insecurity, poor dietary quality), socioeconomic
deprivation at the neighborhood level, and genetic factors that could ultimately influence biological pathways
altering cancer-related fatigue (CRF) risk. Importantly, we recently showed associations between lower dietary
quality and post-treatment CRF among food insecure prostate cancer individuals. One pivotal pathway that may
link dietary adversity to CRF risk is the mammalian rapamycin complex 1 (mTOR/mTORC1) which is involved in
autophagy to regulate cell growth and in energy homeostasis. Our recent work (NR020039) using next-
generation RNA sequencing (RNAseq) from whole blood followed by gene and pathway ontology analyses
identified novel significant associations between the expression of HAS1, PIK3R1, RASA4, SMAD1, TIRAP,
and VEPH1– all related to mTORC1 – with CRF at 1 month after SBRT, suggesting a key role for the mTOR
pathway in CRF. Our evidence highlights the importance of understanding if these risk factors individually or
combined elevate the severity of CRF. The proposed research is guided by a model of SDOH, and dysregulation
of the mTOR pathway in post-treatment fatigue. An experienced team of scientists will conduct the proposed
project, employing rigorous methods using “-omic” approaches to investigate our central hypothesis, by
leveraging our K23 NR020039, that genes involved in mTORC1 and related pathways are differentially
expressed in CRF. We anticipate that dysregulation of mTOR-pathway genes, dietary adversity, and other SDOH
will be enriched in men with prostate cancer who experience CRF. To attain our objective, in a new independent
cohort (n=150) at pre, and 1 month after SBRT, we propose to: 1) validate dysregulation of 6 mTOR pathway
genes in an independent cohort (Aim 1); and 2) determine the impact of dietary adversity, and other SDOH on
post-treatment CRF (Aim 2a) and analyze the contribution of the 6 mTOR pathway genes and dietary adversity
on post-treatment CRF (Aim 2b). At the end of this project, the proposed research will advance management
strategies for cancer-related symptoms by providing proof of the principle of underlying factors that increase risk
of fatigue and support further development and replication of serum biomarkers of fatigue severity and modifiable
biologically relevant therapeutic targets to treat fatigue and improve outcomes in this population.

Public health relevance
PROJECT NARRATIVE Post-treatment fatigue is one of the most frequently reported symptoms distressing patients after receiving five intense short-course of stereotactic body radiotherapy to treat prostate cancer. Questions remain regarding the identification of effective markers that have clinical significance for the risk assessment, prevention, and treatment of fatigue. Examining the relationship between social determinants of health including dietary adversity (food insecurity, dietary quality), and differentially expressed genes of the mTOR pathway with post-treatment fatigue will provide proof of the principle of underlying factors that increase fatigue risk to support further development and validation of serum biomarkers of fatigue severity and modifiable biologically relevant therapeutic targets to treat fatigue and improve outcomes in this population.